HCC Ovarian Cancer SPORE

PROJECT SUMMARY/ABSTRACT – OVERALL
Ovarian cancer (OvCa) has the third highest mortality to incidence ratio and is the fifth leading cause of cancer
death in American women. The typical disease course of a patient with OvCa spans four and a half years from
the time of diagnosis to death. During the course of patient care, acquired and innate resistance to our most
effective and promising therapies, such as chemotherapy, PARP inhibitor therapy, and immunotherapy, drives
disease progression. The overall goal of the UPMC Hillman Cancer Center (HCC) OvCa SPORE is to prevent
and/or overcome therapeutic resistance to improve patient survival. Each of the SPORE’s three Projects
evolved from the innovative concepts and findings of SPORE investigators. Each project involves a clinical trial
with a new agent. In addition, each project, through complementary investigator expertise, incorporates critical
translational aims to identify patients most likely to respond to therapy. Project 1 will assess the ability of
inhibitors of the epigenetic regulator EZH2 to prevent/overcome OvCa stromal progenitor cell-driven resistance
to platinum-based chemotherapy. Project 2 will determine whether BET inhibitors, which downregulate critical
DNA repair and cell cycle checkpoint proteins, can reverse resistance to PARP inhibitors. Project 3 will test
whether inhibitors of the hedgehog signaling pathway, which drives tumor immune exclusion, can improve
OvCa patient response to immune checkpoint inhibitor therapy. The HCC OvCa SPORE will include a Career
Enhancement Program (CEP) and Developmental Research Program (DRP) in order to both encourage early
career investigators to enter the field of translational OvCa research and engage more established
investigators in OvCa research. The CEP and the DRP, which are cost-shared and proactive at providing
research funding to investigators from under-represented minority groups, will provide a pipeline of potential
future SPORE Projects. All SPORE, CEP, and DRP Projects will be receive fiscal and scientific oversight from
an Administrative Core and support from two shared resource cores. The Translational Pathology Core will
collect, annotate, archive, and distribute biospecimens and clinical data derived from the more than 300 HCC
OvCa patients seen each year. It will also develop new preclinical experimental models that behave more like
human OvCa. The Biostatistics and Bioinformatics Core will aid in design and analysis of all studies, including
‘omic’ technologies that can provide molecular and spatial characterization of individual cells within a tumor.
The SPORE Projects will also be supported by established and new collaborators who are internal and
external to HCC. Combined, the SPORE projects, CEP, DRP, and cores are positioned, together with our
vertical collaborators, to improve the outcomes of patients with ovarian cancer. The findings generated by the
SPORE will be advanced through further collaboration and future non-SPORE funding.

Public health relevance
NARRATIVE – OVERALL The goal of the UPMC HCC Ovarian Cancer SPORE is to improve the outcomes of patients with ovarian cancer. We propose (i) three clinical trials, each with critical translational aims to identify patients most likely to benefit from therapy; and (ii) a Career Enhancement Program (CEP) and Developmental Research Program (DRP) to ensure a pipeline of ovarian cancer researchers as well as novel diagnostic and therapeutic strategies. The three projects, CEP, and DRP will be supported by three cores to increase success.